Circadian Organization and Disorder in Alzheimer's Disease

ABSTRACT
With an aging population, the impact of Alzheimer's disease (AD) on public health continues to explode.
Altered daily rhythms in physiology and behavior are prominent features of AD. These altered activity rhythms
are difficult to treat, disrupting the lives of both patients and caregivers. Mounting evidence suggests that these
changes are more than just symptoms. Altered rhythms may contribute to AD progression and development.
Many important transcripts, proteins, and metabolites oscillate with a daily cycle. Understanding these
rhythms, and their influence on AD, offers the potential to identify new therapies.
The translation of circadian biology to Alzheimer's care is limited. Which molecules and pathways show daily
rhythms in our human brains? How do those rhythms change with AD? Do changes in molecular rhythms
explain changing behavioral patterns? Can these rhythms be exploited for therapeutic benefit?
To answer clinical questions, we need human data. AD brain banks provide an invaluable resource. But brain
banks almost never provide the time of day when patients died, making it difficult to use these data for rhythms
research.
We developed CYCLOPS (CYCLic Ordering by Periodic Structure), a machine-learning tool to uncover
molecular rhythms using unordered biopsy samples. Evaluating brain expression data, we showed that
CYCLOPS could correctly reconstruct rhythms in brain samples and correctly predict the time of death.
Here we will order cortical brain samples from control subjects and patients with AD. We will reconstruct the
molecular rhythms in these human brains, identifying differences in AD patients and rhythms in known drug
targets and AD disease pathways.
We will analyze a subset of samples where time of death is known, comparing each subject's “internal
molecular time” with the “time on the clock.” We will test the hypothesis that patients with poorly aligned
molecular rhythms are more likely to have circadian behavioral disturbance. We will evaluate a measure of
transcriptional rhythm strength, testing if “weaker” rhythms predict behavioral or molecular misalignment.
Does AD alter rhythm generation? Does it desynchronize still rhythmic cells and brain regions? Using data
from multiple brain regions sampled from the same subjects, we will evaluate intracortical circadian synchrony
and compare AD patients with controls. Using single-nucleus sequencing data, we will explore the effect of AD
on cell type specific rhythms and their synchrony. Finally, we will test the direct influence of important AD
causing mutations on molecular clock function, measuring rhythms in isolated cells.
This work will advance our understanding of circadian rhythms in AD pathology, clarify the relationship
between behavioral and molecular circadian disruption, and catalyze opportunities for AD chronotherapy.

Public health relevance
PROJECT NARRATIVE Sleep and circadian disruption are prominent features of Alzheimer’s Disease (AD). Circadian, or daily, rhythms influence nearly every aspect of our physiology. This work will help researchers understand how molecular rhythms in the brain may influence the progression of AD, contribute to the sleep disruption experienced by AD patients, and influence the time at which AD targeted medications will be most effective.